Breast Cancer Program

PROJECT SUMMARY – Breast Cancer Program
The Breast Cancer Program (BCP) of the Abramson Cancer Center (ACC) is a multidisciplinary team of highly
productive investigators focused on a common goal: to reduce the burden and mortality of breast cancer by
elucidating biological mechanisms underlying the disease and translating this knowledge to improved
detection, prevention and treatment. BCP members are highly collaborative, working on interconnected
scientific aims that span the continuum from basic science to clinical research. Specific Aims are: 1) Elucidate
the biologic, genetic and molecular mechanisms of breast cancer development and progression; 2) Advance
understanding of genetic susceptibility to optimize screening and prevention for those at risk; 3) Develop
innovative imaging approaches to improve breast cancer screening, detection and biomarkers to guide
treatment and assess therapeutic response, and 4) Translate laboratory discoveries to clinical trials of novel
therapeutics, incorporating biomarkers of response and outcome. Members made fundamental discoveries to
identify breast cancer drivers, mechanisms of tumor dormancy and genome integrity, interferon response, and
the relationship between radiation and immunogenicity. These findings were translated into new targeted
therapeutics, novel combinations, genomic and predictive assays, and cutting-edge imaging methods and
probes. Program members design and implement innovative clinical trials, leading clinical/translational teams
within the ACC, nationally and internationally. In the current funding period, there were 1,386 accruals onto
interventional trials and 14,079 accruals onto non-interventional trials. The complementary skills of Program
co-Leaders (PLs) Angela DeMichele, MD, MSCE (clinical trials/biomarkers) and Roger Greenberg, MD, PhD
(basic science/genetics) facilitate intra- and inter- Programmatic collaborations. With clinical translation of basic
science as a major focus, the PLs expanded clinical research units for breast cancer and genetics, grew and
curated large biospecimen banks, and recruited exceptional senior and junior faculty. These developments
have fostered new ideas and collaborations supported by ACC pilot funds. The PLs also initiated two new
basic science centers, the Center for Genome Integrity and the Mark Foundation Center. The 25 members of
BCP come from seven University Departments and two Schools, reflecting diverse expertise. BCP members
hold $10.4M in cancer-related grant funding (annual direct costs), of which $6.6M is peer-reviewed and $4.3M
is NCI-funded. Members hold 26 R01s or equivalent (of which six are multi-PI awards), an NCI R33 Moonshot
Grant, and a DOD Breast Cancer Center of Excellence. Over the current funding cycle, BCP members
published 403 cancer-related papers, of which 22% were intra-Programmatic collaborations, 37% were inter-
Programmatic collaborations, and 72% were multi-institutional in nature. Supported by senior clinical leaders
within the National Accreditation Program for Breast Centers-accredited Rowan Breast Center, BCP generates
high-impact, practice-changing research, moving the needle on breast cancer treatment and outcomes.